Administrative Core

PROJECT SUMMARY The Administrative Core of the Louisville Superfund Center (LSC) will provide administrative and fiscal support to all Projects and Cores supported by the Center. The Core will be directed by the Center Director, who with assistance from the Program Administrator will facilitate communication and collaboration between individual Cores and Projects, and provide scientific and logistic oversight to Center activities. The Core will act as a liaison for individual Center members in order to best promote collaboration, to ensure all Center work effectively contributes issues relevant to the SRP, and to maximize the dissemination and application of research findings through the Community Engagement Core and the Research Translation Core. To assist in the planning and coordination of research and core activities the Core personnel will organize scientific work-in-progress sessions, biweekly meetings, relevant focus groups, and frequent formal and informal interactions. To integrate cross- disciplinary research, the Core will provide leadership and administrative support needed for integration and coordination of research. The Core will leverage existing resources on campus to optimize the productivity of the Center, and will seek input from both an Internal Advisory Committee and an External Advisory Committee in evaluating progress and in maintaining the relevance of Center activities to the Superfund Research Program mandate. Core leaders will maintain close contact with NIEHS program officials and with UofL administration. Core administrators will also manage the finances and resources of the Center to optimize usage and appropriate allocation. They will also coordinate the timely development of progress reports and financial statements. To ensure quality management, the Core will monitor and facilitate attainment of Center objectives in research, training, education and community engagement, and ensure compliance with state and federal regulations. These activities will minimize administrative burden on Center members, promote communication and collaboration among investigators, and facilitate the sharing of reagents, tools, specimens, and data to ensure the most effective allocation and use of Center funds. The Administrative Core will be the go-to place for students and trainees, community members, public media and press so that all such activities can be appropriately facilitated and coordinated.

Public health relevance
RELEVANCE The Administrative Core is essential for the efficient functioning of the Center. It is required for the Center’s fiscal management and resource sharing, and will ensure quality control and compliance with regulations and evaluation of Center activities. It will facilitate and optimize research, training, community engagement, and research translational activities of the Center, and assist in developing a new understanding of the effects of hazardous chemicals on liver disease, diabetes and heart disease.